Transmembrane Protein 178 as a Novel Endogenous Inhibitory Mechanism in Asthma

PROJECT SUMMARY
Asthma is characterized by chronic, non-resolving lung inflammation; however, there are endogenous inhibitory
mechanisms that normally promote the resolution of lung inflammation. The long-term objective of our research
is to understand the bronchial epithelial cell (BEC)-mediated inhibition of lung inflammation in asthma.
Transmembrane protein 178 (Tmem178) mediates a novel endogenous inhibitory mechanism in asthma. Our
preliminary data showed that TMEM178 gene expression in BECs decreased as asthma severity increased. In
addition, we found that Tmem178 inhibits adenosine triphosphate- and allergen-induced [Ca2+]i responses, store-
operated calcium entry (SOCE), and interleukin (IL)-33 release in BECs. Furthermore, the genetic loss of
Tmem178 led to more severe lung inflammation, airway hyperresponsiveness, and airway collagen deposition
in a murine model of asthma. Finally, we identified TMEM178 variants associated with severe clinical phenotypes
in asthma patients. Based on our preliminary data, we hypothesize that the Tmem178-mediated endogenous
inhibitory mechanism in BECs is dysregulated in asthma, resulting in downstream lung inflammation, AHR, and
tissue remodeling. In this project, we will test this hypothesis by complementary approaches using BEC cultures
and mouse models of asthma together with whole-genome sequencing, RNA sequencing, and clinical data from
diverse asthma cohorts.
In Aim 1, we will test the hypothesis that Tmem178-mediated inhibition of calcium responses is disrupted in
asthmatic BECs. We will analyze calcium imaging from normal and asthmatic BECs and organotypic cultures of
normal and asthmatic BECs. In Aim 2, we will test the hypothesis that the targeted genetic loss of Tmem178 in
epithelial cells results in more severe lung inflammation, airway hyperresponsiveness, and airway collagen
deposition. We will analyze Tmem178fl/flShhCre mice in a murine model of asthma. In Aim 3, we will test the
hypothesis that TMEM178 variants are associated with TMEM178 expression and [Ca2+]i responses in BECs
and severe asthma phenotypes in patients. We will analyze existing whole-genome sequencing, RNA
sequencing, and clinical data from diverse asthma cohorts, and use CRISPR/Cas9 editing to generate and study
TMEM178 variants in BECs. The results of our proposed research will characterize the role of Tmem178 in BECs
and asthma pathogenesis, thereby providing a rationale for the development of novel therapies to resolve
inflammation in the asthmatic lung.

Public health relevance
PROJECT NARRATIVE Transmembrane protein 178 (Tmem178) mediates a novel endogenous inhibitory mechanism in asthma. This project will characterize the role of Tmem178 in bronchial epithelial cells and asthma pathogenesis. Understanding the mechanism of Tmem178 action could lead to the development of novel strategies to inhibit lung inflammation and restore homeostasis in the asthmatic airway epithelial barrier.